Role of intestinal commensal-induced Th17 cells and mucosal immunity in metabolic disease

Project Summary
Obesity and metabolic syndrome are complex physiological conditions that underly many comorbidities,
including cardiovascular disease, diabetes, and inflammatory bowel diseases (IBD). The mechanisms by which
diet-induced obesity leads to disease are incompletely understood and a topic of intense investigation. Changes
in intestinal mucosal immunity, such as decreased barrier function and intestinal inflammation precede and drive
adipose-tissue inflammation. Elucidation of the specific nature and mechanisms by which mucosal immunity
regulates systemic metabolic disease holds promise for conceptually novel targeted interventions for chronic
metabolic diseases. We found that segmented filamentous bacteria (SFB) induce anti-inflammatory Th17 cells
in the small intestinal lamina propria that protect from DIO and pre-diabetic changes induced by feeding mice
with high-fat/high-sugar diet (HFD). Therefore, commensal-induced Th17 cells can protect from systemic
disease. We also found that intestinal Th17 cells decrease intestinal lipid absorption and expression of lipid
sensors in intestinal epithelium. This suggests that Th17 cells modulate epithelial cell function in nutrient sensing
and transport. Here, we propose to examine the mechanisms by which commensal-induced Th17 cells protect
from DIO. We hypothesize that under conditions of increased lipid consumption commensal Th17 cells protect
from DIO by decreasing intestinal inflammation and interfering with lipid sensing and absorption in the intestinal
epithelium. We will test this by 1) examining the role of commensal-induced Th17 cells in preventing or
decreasing HFD-induced dysregulation of mucosal immune homeostasis; 2) testing whether Th17 cells protect
by decreasing lipid absorption and characterizing in detail the effects of mucosal Th17 cells in intestinal lipid
absorption and lipid metabolism of intestinal epithelial cells; and 3) examining the interplay between intestinal
group 3 innate lymphoid cells (ILC3) and Th17 cells in HFD-induced disease and the role of ILC3 and Th17 cell-
controlled microbiota. Altogether, these studies will address fundamental questions on the role of mucosal
immunity, and specifically intestinal CD4 T cells, in protection from metabolic disease.

Public health relevance
Project Narrative Commensal-induced intestinal Th17 cell protect from high-fat diet induced obesity and metabolic disease, but the underlying mechanisms are unknown. Here, we will investigate these mechanisms and more specifically whether intestinal Th17 cells protect by controlling mucosal inflammation and/or intestinal lipid absorption and lipid metabolism of intestinal epithelial cells. Our studies will establish conceptually novel mechanisms of control of systemic metabolic disease by mucosal immunity.